Arginyl-tRNA beyond translation: mechanism and regulation of protein arginylation

Project Summary
Transfer RNA (tRNA) is best known to function in ribosome-mediated protein synthesis. However, in a
less known role, arginyl-tRNA is essential for catalyzing a unique and poorly understood protein post-
translational modification, namely arginylation, that regulates protein turnover. In this arginylation reaction,
ATE1 (Arginyltransferase 1) facilitates arginine transfer to protein targets using a mechanism that
depends on, and is selective for, arginyl-tRNA(Arg) as the donor cofactor. ATE1-mediated protein
arginylation was identified on hundreds of proteins and is recognized as a global regulator of eukaryotic
cellular processes, including embryogenesis, stress responses, and aging. Deregulation of ATE1 is found
in patients with Parkinson’s disease and metastatic prostate, liver, and skin cancers. Nonetheless, how
ATE1 (and other aminoacyl-tRNA transferases) hijacks tRNA from the highly efficient ribosomal protein
synthesis pathways and catalyzes the arginylation reaction remains a mystery. This proposal aims to
elucidate the catalytic mechanism and regulation of ATE1-mediated protein arginylation in vitro and in
cells. We will focus on interrogating the activity of ATE1 and the consequences of arginylation at three
scales. Firstly, we will determine the molecular mechanisms ATE1 selects for arginyl-tRNA(Arg) and
recognizes specific sites in protein targets through an integrative approach combining structural,
biochemical, and biophysical methods. Once determined, this research will allow a better understanding
of the growing classes of aminoacyl-tRNA transferases in general. Secondly, we will quantitatively
determine the consequences of arginylation on target protein turnover in living cells. Protein degradation
usually depends on poly-ubiquitination, a downstream or concurrent event following arginylation, and
through either proteasomal or autophagy-lysosomal pathways. By examining specific model substrates
for proteasome or autophagosome under normal or stressed conditions, we will determine the crosstalk
between arginylation and ubiquitination; delineate the contribution of each degradation pathway; reveal
the kinetics in cells. Lastly, we will investigate whether and how core components of the ribosomal
translation machinery and nutrients affect protein arginylation. Mechanistically, these studies will expand
our knowledge of the regulatory roles of amino acids and tRNAs, enrich our toolbox to study
macromolecule regulation by tRNA-dependent aminoacylation, and reshape how we consider the
functions of the charged tRNAs beyond protein synthesis. Together, this research provides fundamental
knowledge about arginylation, lays the groundwork for discovering novel therapeutic strategies by
modulating ATE1 activity and protein arginylation in Parkinson’s disease and metastatic cancers, and
enables us to build integrative platforms for future research.

Public health relevance
Narrative Protein arginylation is increasingly recognized as a global biological regulator essential for physiological processes, including angiogenesis, embryogenesis, aging, and cell migration. ATE1 is the sole enzyme responsible for protein arginylation and has recently been implicated in human cancers and neurodegenerative diseases, but its catalytic mechanism and regulation remain poorly understood. This project aims to understand the structural, catalytic, and regulatory mechanisms of protein arginylation, which may lead to new therapeutic strategies for preventing the development and progression of Parkinson’s disease and Metastatic Cancer.